Pathobiology of hepatic fibrosis and cirrhosis

Liver fibrosis represents the body’s response to chronic liver injury and appears to be similar
mechanistically to the fibrogenic response in other organs. The result of hepatic fibrogenesis is cirrhosis,
which results in many serious and life-threatening complications. The fibrogenic process is complicated,
yet integrated and tightly regulated. The pathobiology of fibrogenesis includes elements of increased
production of extracellular matrix proteins, tissue contraction, and ultimately, disruption of normal tissue
structure architecture. It has been well established over the last 2 decades that a key cellular effector of
this process in the liver is the hepatic stellate cell. Hepatic stellate cells exhibit a unique characteristic in
that after injury in that they become activated and transform into myofibroblasts. This myofibroblastic
transition is characterized not only by increased production of extracellular matrix (resulting in fibrosis),
but also the programmed expression of multiple different smooth muscle specific proteins, such as the
smooth muscle isoform of actin (smooth muscle  actin - also Acta2), the smooth muscle isoform of
heavy chain myosin, and others. Our hypothesis is that the myofibroblast (i.e., smooth muscle)
transition, through the actin cytoskeleton, is critical in hepatic fibrogenesis; therefore, manipulation of this
program in stellate cells and has the ability to inhibit extracellular matrix production and fibrosis both at
the cellular level and in the liver during injury.
This proposal seeks to break new ground toward a deeper understanding of the molecular basis for
the myofibroblast transition during stellate cell activation after liver injury. We have found that the family
of transcription factors, including myocardin and myocardin related transcription factor, are upregulated
during the myofibroblast transition, and are critical regulators of the smooth muscle protein program
typical of activated stellate cells (myofibroblasts). We present novel preliminary data revealing that the
miR-143/145 complex, important in smooth muscle programming, is important in this process. Therefore,
the goals of this proposal are (1) to study multiple aspects of miR-143/145 molecular regulation and the
functional effects of miR-143/145 depletion in stellate cells and in whole liver after injury and (2) to
investigate the biological effects of myocardin, a key transcriptional regulator of the smooth muscle
program, in stellate cells, in vitro and in vivo. Because myofibroblasts are ubiquitous to many forms of
parenchymal organ wound healing, the proposed studies have substantial implications for wound healing
biology not only in the liver, but also in other organ systems.
The proposed studies are highly innovative because we will elucidate basic mechanisms underlying
the stellate cell to myofibroblast transformation and thus the fibrogenic cascade. As such, targeted
approaches to interrupt this pathway will have a significant impact on Veterans with chronic liver
disease because the data will lead to novel therapeutics that may be used to treat (reduce or prevent)
liver fibrosis.

Public health relevance
Liver damage leads to scaring of the liver in a pathologic process known as cirrhosis. This leads to many different complications that lead to a poor quality of life, including severe intestinal bleeding, fluid buildup in the abdomen, and others. This proposal aims to understand the cause of this scarring in the liver, and ultimately to provide insights that lead to new therapies to treat this problem.